Beyond insulin: Next-generation modulators of insulin receptor for glycemic control

This research project is dedicated to the development and optimization of non-peptide ligands
designed to activate insulin receptors, fundamentally transforming approaches to glycemic control
in the management of diabetes. The innovative strategy at the core of this project involves
designing distinct ligands for insulin receptor binding sites. This approach aims to uncover a new
generation of receptor modulators that might be suitable for oral administration, addressing a
long-standing challenge in diabetes therapeutics. By dissecting and specifically targeting the
insulin receptor binding sites with designed ligands, the project has the potential to yield
unprecedented insights and introduce transformative therapeutic options. If successful, the
outcomes of this research will not only provide a novel and more convenient treatment alternative
for diabetes but will also significantly improve the quality of life and health outcomes for millions
of individuals living with this chronic condition.

Public health relevance
This project proposes to develop non-peptide ligands that activate insulin receptors, offering a new approach for glycemic control in diabetes management. Combining advanced computational design, collaborative expertise, and innovative drug development techniques, the research aims not only to introduce a transformative therapeutic option but also to significantly enhance the quality of life for individuals with diabetes.